Mitochondrial Mechanisms in Asthma

ABSTRACT
One of the most prevalent chronic diseases globally, asthma is characterized by airway inflammation and hyper-
reactivity. Alterations in mitochondrial metabolism and bioenergetics are evident in asthma, but the mitochondrial
genome (mtDNA) has historically been excluded from genome-wide association studies of asthma due to
technical constraints. Mitochondria possess their own circular mtDNA, encoding crucial components of the
Electron Transport Chain (ETC), i.e., Complex I (CI), CIII, CIV, and CV. Unlike nuclear DNA, mtDNA is
exclusively maternally inherited and exhibits a high mutation rate. This leads to accumulation of single nucleotide
variants (SNVs) along maternal lineages, many of which are nonsynonymous in coding regions, resulting in
amino acid changes. While these variants historically played a role in adaptation, changes in modern lifestyles
and longevity compared to our ancestors have shifted their impact towards altering susceptibility to complex
traits and diseases. We hypothesize that homoplasmic SNVs in mtDNA alter bioenergetic capacities and
induce epigenetic changes, collectively influencing asthma risk and pathophysiology. Strong supportive
data include the identification of specific asthma-risk SNVs in population studies and confirmation of
physiological differences among individuals stratified by risk-variant, e.g. CV (A8701G). In mechanistic
investigations, trans-mitochondrial cells in which mtDNA are experimentally exchanged, the cells that harbor an
asthma-risk variant have epigenetic changes linked to nuclear differential expression of asthma-related genes.
Similarly, using a Mitochondrial-Nuclear eXchange (MNX) model with swapped mtDNA and nuclear DNA from
two mouse strains, SNVs in CI (T9461C) and CIV (G9348A) are mechanistically linked to changes in lung gene
expression, higher pro-inflammatory cytokine levels, and mucus metaplasia. In Aim 1, we explore the role of
the mitochondrial genome in asthma. First, we identify associations of mtDNA SNVs with asthma risk and
traits [Aim1A]. Subsequently, we investigate whether risk variants influence mitochondrial functions in circulating
cells and platelets of asthmatics and healthy controls, and determine underlying mechanisms using trans-
mitochondrial cybrids [Aim1B]. In Aim 2, we investigate mitochondrial mechanisms driving asthma using
the MNX genetic mouse model. We examine how SNVs regulate expression of nuclear genes and lung
physiological traits using MNX and wild-type mice under baseline conditions [Aim2A], and assess the impact of
MNX mtDNA variants on lung inflammation, airway reactivity, and mucus metaplasia in an allergen-induced
airway inflammation model [Aim2B]. Together, these studies will enhance our understanding of how mtDNA
variants affect bioenergetics and epigenetics, and contribute to the origins and progression of asthma.

Public health relevance
PROJECT NARRATIVE The major risk for developing asthma is family history, with maternal transmission of asthma risk much higher compared to paternal. Yet, mitochondria with their own DNA inherited maternally, have been overlooked in asthma research, resulting in a large gap in understanding this disease that disproportionately affects women after puberty. This research investigates mitochondrial DNA to bridge the gap in our knowledge of maternal contributions to asthma and ultimately to develop new approaches in prevention and treatment.